Strengthening global food safety through improved capacities for food control at regional and country levels

Project Summary/Abstract
In today’s globalized world, food safety capacities need to be strengthened everywhere to enable more
rational and effective controls in all countries. The main objective of this project is to contribute to the
strengthening of national food control systems through provision of authoritative and practical
guidance, training materials and capacity development activities at global level and in a number of
selected countries.
The proposed approach is based on two complementary pillars, each comprised of activities at global,
and regional/country levels.
Pillar 1 deals with the promotion an support to the sound use of FAO/WHO food control system, which
allows a systematic and reliable evaluation of how national systems are performing and where the
critical weaknesses lie. At country level, the assessment process entails the development of national
action plans for improving the system and verify the achievement of target improvements and thus
promote accountability among decision makers vis-a-vis potential contributing donors or technical
agencies. Successful implementation contributes to reduce food safety risks for domestic consumers in
the beneficiary countries and to promote economic development through increased food and
agricultural exports that meet international sanitary and phytosanitary requirements. As the tool has
now been in operation for some years, it is increasingly becoming important to engage in its
“maintenance” to ensure it remains up to date.
Pillar 2 deals with Strengthening of the evidence and risk basis of official food controls: the shift of the
modern food safety conception from “reactive” to “preventive”, has led governments worldwide moving
towards risk-based approaches to food control activities and requiring all operators in the food supply
chain to bear primary responsibility for food safety. Food inspection programs need to prioritize controls
based on effective risks posed by the food or food operator practices. Planning food inspection based on
risk can be particularly beneficial to developing and transition economies as they make better use of
existing resources by allocating them toward processes and businesses presenting the greatest potential
health risk to consumers and by implementing enforcement action proportionate to the level of risk. In
turns, this also minimizes costs to food operators by reducing unnecessary inspection and testing costs.
A complementary instrument to inspection plans, monitoring (and sampling) programmes are often
overseen by developing countries, as the concepts underlying their basis need to be unpacked. The
scientific advice publications by JECFA and JEMRA, as well as Codex Alimentarius guidelines provide
useful guidance, which would benefit to be supplemented by more practical considerations allowing
countries to replace this guidance into their context.

Public health relevance
Project narrative The main objective of this project is to implement a complementary set of capacity building actions, at global level and in a number of selected countries focusing on risk-based practices and overall comprehensive assessments of food control systems to improve national food control frameworks. Risk-based approaches to food control and identification of the weaknesses in the food control system help minimizing exposure to food hazards, while making more efficient use of the available resources, that may be scarce for many developing or transition countries. In the development and delivery of this project, high importance is placed on coherence with other activities, both in FAO and beyond, to support an optimal and a sustainable outcome, while linkages will be ensured between the technical and the political frameworks to facilitate policy changes based on the improved understanding about where the risks lie.